Translating Scientific Evidence into Practice using Digital Medicine and Electronic Patient Reported Outcomes

Project Summary:
Delivery of healthcare has been traditionally limited to in-person office visits or hospitalizations,
while patients spent the majority of their time at home or work. Digital Medicine (e.g. apps,
remote monitoring, telemedicine, patient reported outcomes
[ePRO]) has the potential to bridge this gap, but it is unclear how to implement in a mainstream
clinical practice that can lead to high-level patient and provider adoption. Through the creation
of a Digital Transformation Network (DTN) for Inflammatory Bowel Disease (IBD), we plan
to reduce digital disparities and scientifically address the evidence gap of digital health
interventions across populations and communities.
AIM I. Unify existing digital assets (mobile app, ePROs, assessment for digital disparities and
behavioral health, referral to IBD home and health education) into an IBD Digital Therapeutics
Toolkit and integrate with EHRs at 3 CTSA hubs. Hypothesis: Integration with EHRs will lead to
higher adoption by providers and limit disruption of workflow.
AIM II: Establish baseline levels of digital connectivity, disease control, quality of life and care
metrics in cohorts at the three IBD centers. Hypothesis: A multipronged approach of
assessment through text, phone, an app, and in-person will yield higher adoption.
AIM III. Implement and evaluate precision-matched interventions (digital skills, social
determinants, behavioral health, monitoring through apps, and referral to
interdisciplinary care) among 1500 patients with IBD using a stepped-wedge, cluster-
randomized trial. Hypothesis: Medical homes supported by a unified platform will translate to
sustainable improvement in population health outcomes. Analyze the Impact of DTN
interventions. The primary outcome will be the improvement of the percentage of patients in
DTN in disease control and decrease in urgent care utilization (emergency department visits
and hospitalization days) across the three CTSA sites.
AIM IV. Support sustainability and dissemination across CTSA sites. Hypothesis: The patient-
centric DTN will be sustainable through alignment with value-based healthcare.
Anticipated Impact: About 2 million Americans suffer from IBD and many more with chronic
inflammatory diseases. We hope that this study will help us build an evidence-based approach
to determine whether digital medicine can engage a diverse group of patients and improve
outcomes; and if yes, how it can be reproduced and replicated across different settings to
address theT3 and T4 translational gaps.

Public health relevance
Project Narrative Delivery of healthcare has been traditionally limited to in-person visits or hospitalizations, while patients spend the majority of their time at home or work. Digital Medicine (e.g. apps, remote monitoring, telemedicine, patient reported outcomes) has the potential to bridge this gap, but the question remains as to how to translate it to mainstream practice while providing individualized recommendations so as to improve population health across organizations. Through the creation of a Digital Transformation Network (DTN) for Inflammatory Bowel Disease (IBD), we plan to reduce digital disparities and scientifically test the impact of these technologies in a clinical trial in three CTSA sites catering to diverse populations and communities.